Sexual Health Empowerment for Cervical Health Literacy and Cancer Prevention

ABSTRACT Women in the criminal justice system are four-five times as likely to have cervical cancer compared to non- incarcerated women. In our previous research, we found that the most important contributor to cervical cancer risk, and perhaps lack of follow-up, is incarcerated women's low health literacy about broader reproductive health issues. Until we effectively address incarcerated women's unique reproductive health literacy needs, the cervical cancer health disparity between incarcerated and non-incarcerated women will persist. The objective of this study is to assess the effectiveness of a sexual health empowerment (SHE Project) intervention to improve cervical health knowledge, reduce barriers to screening that are related to beliefs about cervical cancer, improve self-efficacy for navigating providers and health care systems, and ultimately work towards preventing cervical cancer. This objective is responsive to PAR-10-133 in that it develops an intervention strategy to address health literacy and broader health outcomes in a vulnerable population. To meet the objectives of this study, we propose to assess the impact of a sexual health empowerment intervention (SHE Project) on cervical health knowledge, barriers to screening that are related to beliefs about cervical cancer, and self-efficacy for screening and follow-up among women leaving jail. More specifically, we will conduct a pre- and post-intervention assessment from baseline to the end of a weeklong intervention using a wait-list control design. Next, we will use a three-year observational study design employing both survey and ethnographic methods for follow-up, to understand how knowledge, beliefs, self-efficacy, and other factors change post-release cervical health prevention behaviors over time. This approach will allow us to observe the extent to which women translate, if at all, increased knowledge, reduced barriers, and increased self-efficacy into practice during clinical encounters, or if other factors explain health behaviors over time. The public health impact of this study is its potential to reduce cervical cancer morbidity and mortality for this high risk and vulnerable group of women. Our development of an effective and easily disseminated health literacy intervention that can be adapted to many health conditions and broader cancer prevention efforts in institutionalized populations (jails, prisons, community corrections, military institutions) will have an impact on public health, and also on the science of developing effective health literacy interventions.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The public health impact of this study is its potential to reduce cervical cancer morbidity and mortality for the high risk and vulnerable group of women in the criminal justice system. An empowerment approach to health literacy interventions will also have an impact on broader reproductive health problems in this high risk population. Further, the development of an effective and easily disseminated health literacy intervention that can be adapted to many health conditions and broader cancer prevention efforts in institutionalized populations (jails, prisons, community corrections, military institutions) will have an impact on public health, and also on the science of developing effective health literacy interventions. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Women in the criminal justice system are four-five times more likely to have cervical cancer compared to non- incarcerated women,1,2 but little is known about how to address this health disparity. The one million women incarcerated in the US - 95% of whom will return to their communities - are mostly poor, racial/ethnic minorities,3,4,5 with long histories of abuse, mental health problems, drug use, and STIs.6,7,8These complex factors exacerbate their risk for cervical cancer, as well as create barriers to follow-up health care. The few investigators that have studied cervical cancer among women in jails and prisons have found that, indeed, though many women get screened for cervical cancer, less than half gain access to recommended clinical follow-up.9,10 In our pilot research, we found that the most important contributor to cervical cancer risk, and perhaps lack of follow-up, is incarcerated women's low health literacy about both cervical cancer and broader reproductive health issues.11 Until we effectively address incarcerated women's unique reproductive health literacy needs, given the barriers of incarceration, release, and traumatic life experiences, the cervical cancer health disparity between incarcerated and non-incarcerated women will persist. The long-term goal of this project is to improve incarcerated women's reproductive health literacy in order to bolster cervical cancer control efforts in this population and reduce the cervical cancer disparity between incarcerated and non-incarcerated women. The primary objective of this study is to assess the effectiveness of a sexual health empowerment (SHE Project) intervention to improve cervical health knowledge, reduce barriers to screening that are related to beliefs about cervical cancer, improve self-efficacy for navigating providers and health care systems, and ultimately work towards preventing cervical cancer. This objective is responsive to PAR-10-133 in that it develops an intervention strategy to address health literacy and broader health outcomes in a vulnerable population. To meet the objectives of this study, we propose the following aims: AIM 1: Using an experimental design, assess the impact of a sexual health empowerment intervention (SHE Project) on cervical health knowledge, barriers to screening that are related to beliefs about cervical cancer, and self-efficacy for screening and follow-up among women leaving jail. To achieve this aim, we will conduct pre- and post-intervention assessments at baseline, and at the end of a weeklong intervention using a wait-list control design. The intervention's health empowerment approach to health literacy capitalizes both on unique problems of incarcerated women (sexual violence, disempowerment, discrimination, poor reproductive and cervical health outcomes) and on the institutionalized setting where dissemination of interventions is feasible and cost-effective. Outcome variable selection is guided by our prior research (NCI R03 and ACS pilot) on cervical cancer health literacy with women in jail, where we documented deficits in knowledge, beliefs, and self-efficacy in navigating providers and health care systems relating to these women's reproductive health. Thus, for AIM 1, changes in knowledge, beliefs, and self-efficacy pre- and post-intervention are the primary outcomes of interest. AIM 2: Using a three-year observational design employing both survey and ethnographic methods for follow-up, understand how knowledge, beliefs, self-efficacy, and other factors change post-release cervical health prevention behaviors over time. This aim will allow us to observe the extent to which women translate, if at all, increased knowledge, reduced barriers, and increased self-efficacy (AIM 1) into practice during visits with clinicians. We also will be able to analyze which components of the intervention are associated with appropriate preventive health behaviors, or if other observed factors account for screening and follow-up over the three-year study period - for example, factors unrelated to the intervention, such as cost, transportation, or ongoing criminal justice involvement. The main barrier to cervical cancer prevention for women appears to be loss to follow-up, but little is known about what accounts for loss to follow-up. This aim will demonstrate whether an intervention that addresses knowledge, beliefs, and self-efficacy translates to improved screening uptake and follow-up, or if other factors explain poor cervical health screening behaviors. The primary outcomes for this observational AIM 2 are screening behaviors (Paps or STIs), clinical follow-up of screening, and strategies for navigating health care encounters. Knowledge gained from this study will translate to the dissemination of strategies to improve reproductive health in high-risk incarcerated women, and address health literacy in light of the unique challenges this group of women face. The interdisciplinary team of investigators, which has both a strong history of working together and excellent access to the target population, is well prepared to conduct this R01 project that entails designing, implementing, and evaluating the effectiveness of a novel cervical cancer health literacy program.